Mechanisms Linking Hearing Loss and Alzheimer's Disease and Related Dementias

The proposed K23 award will provide Justin S. Golub, MD, an assistant professor of otolaryngology—head and
neck surgery at Columbia University Medical Center, with mentored career development to establish an
independent research career in the study of the relation of hearing loss (HL) to Alzheimer’s disease (AD) and
related dementias (ADRD). Age-related HL is the third most common chronic condition in older adults and is
associated with ADRD, cognitive decline, and brain atrophy. However, the mechanisms underlying these
associations are unknown. The goal of this career development award is to advance Dr. Golub’s research career
in HL and ADRD by (a) providing mentored career development and training in patient-oriented research (POR);
and b) conducting research to elucidate the mechanisms underlying the association of HL with ADRD in an
ancillary study of an ongoing project, in which the primary mentor, José Luchsinger, is the principal investigator.
This project will inform the development of future POR in HL and ADRD. Career development will be provided
through an experienced team of mentors spanning the disciplines of aging, geriatrics, neuropsychology,
neuroimaging, epidemiology, and otolaryngology. Training will occur in 6 key areas: (1) aging and ADRD; (2)
implementing hearing assessments in POR; (3) brain imaging; (4) cognitive testing; (5) biostatistics and
epidemiology related to POR in ADRD; (6) professional development. Modes of learning will include meetings
with mentors, formal courses in career development, formal courses in epidemiology and biostatistics, seminars
in aging and ADRD, training and participation in primary data collection, scientific meetings, and training in the
responsible conduct of research. Preliminary studies from the applicant revealed a 70% increased risk of ADRD
in the elderly with observed (not measured) HL compared with those without observed HL. The research goal of
this award is to examine the associations of objectively measured HL with imaging markers of ADRD and
cognitive performance in late middle aged persons. This will be the first step towards elucidating the mechanisms
of the association between age-related HL and ADRD. We will accomplish this by adding an audiometric hearing
test to an existing longitudinal study of imaging markers of ADRD in late middle age. This study includes
longitudinal ascertainment of AD, neurodegeneration, and cerebrovascular disease (CVD) on brain imaging, as
well as cognition. AD is ascertained as whole brain amyloid β with 18F-Florbetaben positron emission tomography
(PET). Neurodegeneration is ascertained as tau in inferior and medial temporal lobes with 18F-THK5351 PET,
and brain atrophy with magnetic resonance imaging (MRI). CVD is ascertained as white matter hyperintensities
and infarcts on MRI. Cognitive testing includes memory and executive function. We hypothesize that HL is
associated with AD, neurodegeneration, and CVD, and these associations mediate the association between HL
and worse cognitive performance. The proposed career development activities and research project will help
propel a career to clarify whether HL is a cause, consequence, or correlate of ADRD.

Public health relevance
Age-related hearing loss (HL) is a common condition (present in over 80% of those over 80 years) that is associated with Alzheimer’s disease and related dementias (ADRD). The proposed award will support a career to clarify the mechanisms linking HL and ADRD, including whether HL is a cause, complication, or correlate of ADRD. This goal is in line with 2 goals of the National Alzheimer’s Project Act (NAPA) to “prevent and effectively treat Alzheimer’s disease by 2025,” and “expand supports for people with Alzheimer’s disease and their families.”